Emerging zoonotic malaria in Malaysia: strengthening surveillance and evaluating population genetic structure to improve regional risk prediction tools

Project Summary/Abstract
Southeast Asia remains a global hotspot for emerging zoonotic infectious diseases. The recent
increase in transmission of the monkey malaria parasite Plasmodium knowlesi, endemic to
Southeast Asia, exemplifies how land-use change can drive disease spill-over to humans. In
Malaysia, P. knowlesi now accounts for the vast majority of malaria cases and is the
predominant cause of malaria-related deaths. Recent reports suggest that P. knowlesi is also the
predominant species in parts of western Indonesia, and that due to misidentification by microscopy,
under-diagnosis is likely widespread across the region. Molecular surveillance is essential for
monitoring the emergence of zoonotic P. knowlesi, informing malaria control strategies, and
assessing progress towards elimination of the human-only malaria species.
In this study in Sabah, Malaysia, we firstly plan to further improve molecular state-wide malaria
surveillance detection systems to monitor for changing epidemiological and clinical features of
disease, including in pregnancy, which potentially could occur with adaption of P. knowlesi to
human-human transmission. We will supplement these data with targeted longitudinal health
facility surveys of healthy and febrile attendees to understand the true burden of asymptomatic or
submicroscopic P. knowlesi infections, in addition to screening for other simian malaria species
such as P. cynomolgi. A high-throughput multiplex serological malaria surveillance platform will
also be used to integrate recently developed novel antigens targeting P. knowlesi. This platform
will enable evaluation of population-level markers of P. knowlesi exposure and transmission
intensity in the context of potential waning cross-species immunity from other human malaria
species, and allow concurrent assessment of other public health priorities including SARS-CoV-2.
Secondly, recent advances in multiplexed deep targeted sequencing of microhaplotypes offer
potential advantages if these tools are adapted for P. knowlesi. Our previous surveillance study
collected >5500 P. knowlesi isolates, and we plan to develop novel genome-based tools to evaluate
P. knowlesi population structure at sufficient resolution to understand increasing transmission and
disease severity in Sabah, and relate these findings to elsewhere in Southeast Asia. Finally, we will
also use an updated georeferenced database of state-wide P. knowlesi cases over time to
characterise changing fine spatial scale incidence patterns, and to generate regional predictive P.
knowlesi risk mapping incorporating environmental remote-sensing satellite data and predicted
human, monkey and mosquito population distributions to inform and guide planning, surveillance
and prevention activities in other countries in the region at risk of P. knowlesi transmission.

Public health relevance
Project Narrative The zoonotic malaria species P. knowlesi has emerged as a major public health problem across Southeast Asia, highlighted by the increasing number of reported cases in the epicentre of Malaysian Borneo, and threatens regional malaria elimination goals. In this state-wide malaria surveillance study in Sabah, Malaysia, we will evaluate these changing malaria trends using improved integrated molecular and serological detection platforms, and develop novel genomic based tools for P. knowlesi to look at how parasite population structure impacts on transmission and disease severity, including in the context of potential adaption to human-human transmission. Finally, we will use cutting-edge predictive geospatial risk mapping of P. knowlesi occurrence data and environmental and biological covariates in order to inform malaria control programs in Malaysia and other endemic countries in the region; promoting an improved targeted regional surveillance strategy and ability to prepare for and address the risk of increasing P. knowlesi transmission.